Gene Regulation During Early Development c.Elegans

DESCRIPTION (provided by applicant): We propose to continue a multidisciplinary project to understand the mechanisms by which aberrant, unusual, or foreign RNA and DNA structures trigger gene silencing. The major aims of this project are: 1. Establish the mechanisms by which miRNA, siRNA, and piRNA effectors repress their genetic targets. Thirty years of careful molecular-genetic analysis of developmental progression in C. elegans, combined with new technologies for genome editing, provide a remarkable ability to make targeted changes in place in genomic contexts that will allow us to address specific physiological regulatory mechanisms in vivo. Adding the intensive genetic analysis of small RNA targeting machineries that has been performed in C. elegans yields a platform to definitively assign silencing mechanisms for each of the major small RNA regulatory classes. Assigning these mechanisms should provide important guidance in understanding small RNA-based effects on physiology and disease and in applying small RNAs as modulators in experimental and therapeutic contexts. 2. Investigate mechanisms used by organisms to recognize and silence foreign DNA. Along with an ability to recognize and target foreign or aberrant RNA, cells have sets of mechanisms to recognize and silence foreign DNA molecules introduced by injection or other routes. In some aspects, such mechanisms overlap with known foreign RNA defense mechanisms, while certain features of the foreign DNA response are not easily explained by current RNA-based silencing models. We will analyze a set of non-cannonical triggering events and downstream silencing processes with the long term goals of understanding DNA-triggered silencing mechanisms, being able to defeat these mechanisms for specific experimental or therapeutic goals that involve expression of foreign DNA, and of being able to co-opt DNA silencing as needed to flexibly block specific gene expression. 3. Investigate the mechanisms by which new small RNA effector repertoire is acquired by the genome. Genomic regions encoding small RNA effectors show a remarkably dynamic character, allowing acquisition of new silencing capabilities and thus protection against novel invasive agents as appropriate specificities are added to the repertoire. Little is known about how new small RNA repertoire is added, with recent technical advances in sequence analysis allowing these questions to be addressed both on a structural level (what structures give rise to new elements of the repertoire) and on a functional level (how new sequence acquisitions are executed). Understanding of RNA repertoire acquisition will be of considerable value, (i) in guiding our views on the role and capabilities dynamic small RNA regulatory systems, (ii) in illuminating any conditions resulting from inability to adapt and thus respond to novel pathogens, and (iii) in providing a potential entry into using the system for directed repertoire expansion to provide experimental or therapeutic intervention.

Public health relevance
PUBLIC HEALTH RELEVANCE: A greater understanding of signals that activate and silence regions of the genome will illuminate the fundamental mechanisms that our cells use (i) to properly control the activity of each of their genes and (ii) to protect themselves from unwanted genetic activity in the form of viruses and other genomic parasites. This research program applies a variety of information-based and experimental approaches directed toward that understanding.